Addressing Community Concerns and Assessing Exposures and Alternatives to Artificial Turf Fields and Playgrounds

Project Summary
Artificial turf fields and playgrounds have become common playing surfaces. It is estimated that
there are over 13,00 fields, and up to 1,500 new artificial fields are installed each year. Most of
these fields and playgrounds utilize infill generated from recycled tire crumb. Communities have
consistently reported chemical smells in fields, playgrounds, and surrounding areas. Despite the
widespread usage of artificial turf fields and playgrounds, uncertainty remains about safety and
the potential for exposure to toxic chemicals, heat exposure, impacts resulting in injury, and
environmental impacts in the community. Many studies have identified the presence of toxic
chemicals, known to be neurotoxic and carcinogenic in tire crumb infill. Parents and communities
are concerned because young children and athletes could be exposed and could potentially
experience health effects in the future from playing on these surfaces. Laboratories have identified
toxic chemicals in tire crumb, but results of exposure assessment information generated under
realistic playing conditions in children and adults are very limited. Exposure assessment studies
are underway at a state and federal level. Despite that, an increasing number of communities are
opting to use alternative infills made from plastics, virgin rubber, silica sand, cork, and waste shoe
materials. However, as with tire crumb infill, safety information is also lacking. As such,
communities in general struggle to make informed decisions about safe playing surfaces. The
proposed community-engaged project will employ a citizen science approach to collect samples
from alternative infill fields, identify chemicals in alternative infills materials, and characterize
exposure in such fields under real-life conditions. This project is well-positioned to achieve our
goal to address concerns from the community and inform policymakers in their communities to
incorporate environmental health research into consideration during the decision making for the
procurement, installation, use, and disposal of playing surfaces. This project embraces the
involvement of community member participation in the project’s research activities. Active
community involvement will allow community members to gain first-hand knowledge of the
chemicals in their fields and heat during playing conditions. Most importantly, it will enable them
to assist other communities regarding better practices and effective policies to protect concerned
communities.

Public health relevance
Narrative Many studies have documented the presence of toxic chemicals in existing artificial turf fields and playgrounds. New materials are increasingly being used as alternatives in playing surfaces, but safety information is still lacking. Using a citizen science approach, we will characterize the chemicals in new materials and comprehensively evaluate the exposure of children to chemicals and heat under real-use conditions. The project campaign will communicate research findings among partnering organizations and communities at large.